CORE--ADMINISTRATION AND LABORATORY SUPPORT

DESCRIPTION (provided by applicant): The goal of the Administration Core is to provide efficient management of the U54 Cooperative Contraceptive Research Center within the overall context of the Contraceptive Development program at the Population Council's Center for Biomedical Research. The Core will provide graphic illustration services to Core B, Center investigators and other U54 Center staff as well as secretarial and other office support. Administrative support for all Center activities is included in the objective of this Core, such as supporting the Director in her leadership of the Center; arranging for meetings among Center investigators and Core Directors, and visits by other scientists; assisting in the preparation of all publications, regulatory documentation, and scientific presentations; and providing laboratory support services through the Glassware Washing Facility. The organization of the Core is straightforward in that all the personnel are responsible to the Core Director. The Core Director reports to the Vice President of the Center for Biomedical Research. Day-to-day operations are overseen by Dr. Sitruk-Ware in consultation with Dr. Ashton Barfield on matters involving financial management, and with Ms. Kim Bailey of the Human Resources office on personnel matters. The Core serves the U54 Cooperative Contraceptive Research Center projects and Core B equally, with 20% of its services allocated to each.